BLOOD PROGENITOR CELL MOBILIZATION BY R-METHUSCF &R-METHUG-CSF IN BREAST CANCER

To compare the number of aphereses required to harvest at least 5 x 10-6 CD34+ cells/kg actual body weight, using either r-metHUSCF in combination with Filgra-stim or Filigrastim alone for mobilization or progenitor cells in patients with high risk Stage II, Stage III or Stage IV breast cancer. To demonstrate equivalent engraftment, as assessed by recovery of neutophils and platelets, PBPC mobilized by either r-metHUSCF plus Filigrastim or Filgrastim alone when used as cellular support post high dose chemotherapy.